NMR Core

NMR Core
The overall goal of the NMR Core is to provide state-of-the art capabilities for PCHPI researchers, for atomic-
level characterization of structure and dynamics of HIV-1 proteins and their complexes. To accomplish this goal,
we will take advantage of superb instrumentation resources, innovative experimental protocols, and unique
expertise developed during the past decade. Specific aims are designed to i) support PCHPI projects and extra-
center collaborators by providing cutting-edge solid-state NMR capabilities for HIV-1 research, and ii) develop
in-cell solution and solid state 19F NMR for HIV-1 research. The novel technologies developed by the NMR Core
will have major impact on HIV-1 cellular structural biology.